Clinical Translation of Nuclear Export Inhibitor in Metastatic Pancreatic Cancer

Abstract/Summary: Mutations in KRAS are among the most common aberrations in cancer. Mutant KRAS
drives proliferation and survival through canonical RAS-RAF-MEK-ERK-RSK (RAS-RSK) signaling. While
KRASG12D, a major mutation found in cancers remains undruggable, a smaller subset of patients carry KRASG12C
mutation for which new targeted drugs have emerged. Several KRASG12C inhibitors have been studied in pre-
clinical and Phase I/II/III studies and one such inhibitor sotorasib has received FDA approval for KRASG12C mutant
NSCLC patients. Despite this success, the objective response rates from sotorasib or other related inhibitors has
been modest and durability of response needs to be improved. A number of resistance mechanism have been
proposed and strategies to overcome therapy resistance to KRASG12C inhibitors is a topic of intense
investigations. We have discovered that proteins in the RAS can influence the nuclear protein transport. In normal
cells, the export of nuclear cargoes is mediated by the Karyopherin family protein exportin-1/XPO1 through
nuclear export signal sequence recognition and is facilitated by a RAS downstream effector RanGTP. This
makes RAN a mediator between growth signaling and nucleocytoplasmic transport that can be activated through
classical RAS-RSK pathway. Ran binding protein 3 (RanBP3) is recognized to be phosphorylated through RSK,
resulting in the promotion of RanGDP to RanGTP conversion through RCC1 thereby enhancing Ran-dependent
nucleocytoplasmic transport (schema). Such over-active nuclear export has been shown to promote therapy
resistance through mislocalization dependent inactivation of tumor suppressor proteins. More significantly, our
new findings show that specific inhibitors of nuclear export (SINE) compounds can enhance the efficacy of
KRASG12C inhibitors. We hypothesize that SINE-KRASG12C inhibitors could become a unique combination for
KRASG12C mutant tumors. Additionally, studying this unique combination will also help uncover the tangible link
between KRAS and nuclear protein export signaling. Our specific aims are Aim 1. Characterize the synergy
between SINE compounds and KRASG12Ci using high throughput strategies. Aim 2. Demonstrate synergy
between SINE KRASG12Ci using patient derived xenograft. Impact: Mutant KRAS remains an impenetrable
fortress and an unmet clinical need. This work will lead to the advancement of a novel combination that target
two highly sought after cancer targets i.e. KRASG12C and XPO1. Additionally, the proposed experiments will also
enhance the fundamental understanding of the interaction between mutant KRAS and nuclear protein export
pathways and its consequence of therapy resistance. The proposed pre-clinical studies will bring forward a new
and personalized therapy for KRASG12C mutant driven resistant tumors.

Public health relevance
Narrative: Mutant KRAS protein drives several cancer related pathways and remains a highly sought after target. We have discovered that targeting nuclear transporter XPO1 by specific inhibitors of nuclear export drugs can synergize with KRAS targeted drugs. We will perform critical pre-clinical analysis of this synergy to bring forward a novel and effective combination therapy targeting the KRAS and nuclear protein transport axis in oncogenic RAS driven tumors.